Inter-regional study of transmission, adaptation and pathogenesis of viruses with pandemic potential in Southeast Asia and West/Central Africa

Project Summary/Abstract
We will establish an Emerging Infectious Disease Research Center in Southeast Asia and West/Central
Africa with an inter-continental one health approach designed to improve the capacity to respond rapidly
and effectively to outbreaks. Our proposal is built on an existing network of laboratories/epidemiologists in
close contact with national healthcare systems. We will identify factors influencing emergence and
transmission at the virus, vector and reservoir level, leading to epidemics in suspected spillover conditions.
We will focus on high priority RNA viruses with epidemic potential in Africa (Rift Valley Fever virus (RVFV),
Crimean Congo Hemorrhagic Fever Virus (CCHFV)) and in Southeast Asia (dengue virus (DENV)) as well
as viruses (Disease X) identified from symptomatic surveillance or insect sampling. We will tackle problems
in emerging infectious diseases by the following specific aims: 1) Enhance surveillance and detect
unknown RNA viruses with potential for spillover to humans. We will implement an autonomous
solar-powered mobile suitcase laboratory for rapid pathogen identification in the field. Connection to a
cloud computing system will facilitate data analysis and sharing among healthcare centers and laboratories.
We will survey pathogens present in insects in different ecological settings. We will develop new diagnostic
tools for these viruses and conduct prevalence and behavioral studies in human populations to determine
risk factors. 2) Understand transmission dynamics of endemic RNA viruses with high risk of
outbreak. We will focus on RVFV and CCHFV in Senegal and Cameroun, and DENV in Cambodia. We will
perform surveys in animals and humans using a more specific multiplex assay. We aim at obtaining better
knowledge on prevalence, transmission dynamics, and identifying major insect vectors and animal
reservoirs. 3) Understand factors influencing adaptation of RNA viruses to new hosts. We will use
state of the art technology to generate and study key candidate viral mutations using cells from relevant
species including humans. We will study efficacy of these viruses in infection of various strains of insects to
estimate transmission risks. This aim will lead to better understanding of the adaptation of these viruses to
new hosts and will help design more detection methods. Lastly, 4) Study of host adaptive immune
responses to emerging infectious diseases in South-East Asia and Africa. We will increase our insight
into the adaptive immune response at a single cell level and the sequence-function relationship of human
antibodies generated during infectious diseases (DENV, RVFV, CCHFV) by combining sequencing at a
single cell level with antibody repertoire analysis. We will study function and characterize structure at a
single antibody level. We will provide novel understanding of the role of cellular immunity in DENV disease.
The proposed activity will allow the implementation of infrastructure and an analysis pipeline for outbreak
preparedness in areas where viruses with potential pandemic threats circulate.

Public health relevance
Project Narrative In recent years, there have been several outbreaks, such as Ebola and Zika, that have struck the world. We will set up research infrastructure and pipeline in countries where further outbreaks are likely to occur to study how viruses from animals and/or insects could adapt themselves to infect humans and cause outbreaks. The study will help us to better prepare to prevent and to react faster and more efficiently to the future outbreaks.